An unconventional regimen comprising biofilm disruptor as an adjunct with antibiotics to treat Mycobacterium abscessus chronic lung disease

PROJECT SUMMARY
Mycobacterium abscessus (Mab) is a rapidly growing non-tuberculous mycobacterium that can cause chronic
lung disease that is associated with rapid lung function decline and is often incurable. There are no FDA-
approved treatments for this indication. Patients report to the clinic with chronic disease and reduced lung
function, and for the majority of them, the optimistic objective is to effectively manage the condition to prevent
its deterioration, given that current treatments are largely ineffective in achieving a stable cure. In the course
of chronic disease, Mab develops biofilms in the lungs, creating a protective shield against antibiotics. Existing
treatments are based on repurposing of antibiotics approved for other diseases. Challenges of the currently
recommended standard treatment of Mab lung disease include a) poor efficacy, b) need for treatment
durations lasting several months, c) frequent drug toxicities, d) need for parenteral (IV) antibiotics, and e)
complicated logistics of long-term outpatient IV antibiotic treatment. The cure rate using current treatment
recommendations is estimated at 30-50%. One reason commonly cited for the limited effectiveness of
antibiotics against Mab disease, as well as the need for prolonged treatment durations, is their challenge in
efficiently penetrating and eliminating the Mab subpopulation present in biofilms.
The overall aim of this proposal is to generate proof-of-concept data on a non-traditional strategy that
acknowledges the necessity of disrupting Mab biofilms. For antibiotics to demonstrate the anti-Mab activity
observed in in vitro settings, where antibiotics effectively kill planktonically growing Mab, it might be essential
to first destroy Mab biofilms in the lungs. CMTX-101 is a monoclonal antibody that works to disrupt Mab
biofilms by removing DNABII proteins, which are crucial for the lattice organization and stability of DNA
providing structural integrity to Mab biofilms. Given its effective disruption of Mab biofilms in vitro, we aim to
investigate in a mouse model of chronic Mab infection whether CMTX-101 can similarly disrupt Mab biofilms
in the lungs. If CMTX-101 can effectively modify Mab biofilms in the lungs, the results from the proposed
studies can serve as proof-of-concept for an unconventional approach to treating not only Mab disease but
also other conditions where bacterial biofilms pose a challenge to effective treatment.

Public health relevance
NARRATIVE Mycobacterium abscessus, a rapidly growing non-tuberculous mycobacterium, causes life-threatening opportunistic infections in individuals with structural lung conditions such as bronchiectasis, cystic fibrosis, and chronic obstructive pulmonary diseases. In the course of chronic disease, M. abscessus develops biofilms in the lungs, creating a protective shield against antibiotics. This proposal seeks to explore the idea that a monoclonal antibody, CMTX-101, capable of disrupting biofilms, can effectively target M. abscessus biofilms in the lungs of mice, ultimately enhancing the efficacy of antibiotics.